Hippocampal Sharp-Wave Ripple and Replay Mechanisms Underlying Long-Term Memory

Project summary
The mammalian brain has the remarkable capacity to store and retrieve memories. In particular, salient events
called sharp-wave ripples (SWRs) are implicated in the consolidation and recall of memories in the hippocampus.
These events are high frequency oscillations caused by synchronous depolarizations across both hippocampal
hemispheres, and they occur during awake rest or sleep. During SWRs, neural ensembles that are activated
during awake experiences are reactivated in rest in compressed sequences of short durations, a process called
‘replay’. Because of their large-scale nature, sharp-wave ripples and replay events can potentially shape
plasticity within hippocampal ensembles to promote memory. Studies have shown that lengthening the duration
of SWRs can improve memory on spatial tasks performed less than 24 hours later, while disrupting SWRs will
impair memory on these spatial tasks. Though SWRs can influence memory processes on short timescales, their
role in preserving memories across long timescales remains largely unknown. This proposal will explore the
hypothesis that SWRs enhance the stability of long-term memories by generating plasticity to form and maintain
ensembles.
We will investigate how SWRs shape the stability of spatial memories encoded in hippocampal region CA1 during
navigation in virtual reality environments. This study will address two aims. In Aim 1, we will measure the effects
SWRs have on the stability of the population-wide place code and replay events across weeks. The proposed
experiments will leverage in vivo two-photon calcium imaging and electrophysiological recordings to evaluate
whether SWRs causally create stable ensembles on the population level across weeks. In Aim 2, we will
determine how SWRs and replay events shape microcircuit organization within replay ensembles. These
experiments will utilize a high-speed two-photon optogenetic stimulation approach to optically measure causal
functional connectivity between cells within the replay ensemble and to determine whether SWRs can generate
plasticity to recruit cells into the replay ensemble. We hypothesize that SWRs contribute to establishing
temporally stable memory traces by strengthening the causal functional connections within replay ensembles.
These results will provide insight on neural mechanisms that stabilize memory ensembles across long
timescales, which is critical for understanding how long-term memory processes are implemented. Long-term
memory is impaired in patients with memory disorders and conditions such as Alzheimer’s disease, dementia,
and amnesia, so findings from this proposal will help provide a foundation for understanding the pathology of
these conditions and will help in the development of new therapies for these patients.

Public health relevance
Project narrative These studies will use two-photon calcium imaging, single-cell photostimulation, and electrophysiology methods in vivo to investigate how hippocampal sharp-wave ripples and replay events shape and stabilize memory ensembles. Results from this proposed study will provide valuable insight on the population-wide and microcircuit mechanisms underlying long-term memory. By advancing our knowledge of the neural mechanisms of long-term memory in hippocampal networks, we can develop more effective treatments and interventions for memory- impaired clinical populations, such as patients of Alzheimer’s disease or dementia.